Examining the Effects of Disability on Citizenship in the Early United States, 1775-1840

Project Summary/Abstract
In the decades after the American Revolution, citizens imposed significant restrictions on
physically and intellectually disabled people’s legal, political, and social rights. Increasingly towards the
mid-nineteenth century, these restrictions were justified with medical theories and managed and
implemented by physicians. As a result, disabled people—men and women, black and white, wealthy and
poor, from across the nation—lost access to basic civil rights and privileges, including suffrage, marriage,
property ownership, and independent living. At the same time, this project documents how disabled
people challenged the exclusions they faced, claiming knowledge of the functioning of their bodies and
minds as they fought for greater access and opportunity. Just as ableism has a long American history so
too does disability rights activism as individuals used legal, political, institutional, and physical means to
claim their status as equal citizens.
This narrative of ableist exclusion, medical justification, and disability rights resistance has long
been overlooked in accounts of our nation’s history. Scholars in the fields of early American history and
the history of medicine have been slow to attend to disability and integrate findings from the discipline of
disability studies into their work. Scholars in disability studies, meanwhile, have tended to focus on more
recent historical periods. Academic oversight of early American disability history has also shaped popular
national narratives. Museums, historical societies, and the media all rarely feature disabled people when
they chronicle our nation’s founding period. Drawing on nearly a decade of primary source research in
legal, medical, governmental, institutional, and genealogical records, this project centers disabled people
to tell a more accurate and inclusive national story—crucial as our country nears its semiquincentennial
anniversary in 2026.
With publication (the manuscript is committed to a top academic press), this project seeks to
accomplish three aims. First, it documents the structural ableism that defined our nation’s founding
period. Second, it reveals how physicians rationalized ableist exclusions and implemented them in legal,
political, institutional, and social settings. Third, the work chronicles the resilient individuals who
challenged these restrictions as they worked to improve their lives, families, and communities. This
history is crucial for a full and accurate understanding of our early American past as well as critical
context as we confront and challenge ableism today.

Public health relevance
Project Narrative This project documents the role of medicine and physicians in barring disabled people from many legal, political, and social rights, such as marriage and voting, in the decades after our nation’s founding. Health professionals, public health officials, and historians of medicine must recognize medicine’s historical role in supporting and defending structural ableism. Such an awareness provides crucial context for present-day work for greater access and equality in medicine and American society more broadly.